UW Post-Baccalaureate Research Education Program (PREP)

The biomedical research community is underrepresented in populations of certain ethnic origin, with disabilities
and of disadvantaged background. The University of Washington PREP program (UW PREP) provides UR
students with research and professional development training to enter biomedical graduate programs. The
program has done so for 13 years by recruiting recently graduated UR students; (providing them with research
experience at the UW and the FredHutch; as well as in professional development through graduate courses at
the UW, specialized seminars and mentored presentations; present their research at national conferences; and
individual mentorship. UW PREP has recruited 86 fellows; 83% of fellows overall (but nearly 90% in the
second and third cycle, years 5-12) have reached graduate school in premier biomedical research programs;
of these, 20 have graduated with PhD’s and 7 with Master degrees, while 28 are still enrolled in graduate
school (82%); the majority of all other fellows are still involved in biomedical research or teaching.
The outstanding results of UW PREP demonstrate that its plan to advance the fellow’s preparation
centered on a year-long research patterned project (approximately 75% of the time), supplemented by targeted
professional development activities (25% of the time) will allow UW PREP fellows to be admitted to and
succeed in high-quality biomedical doctoral programs. One of the main reasons for the success of UW PREP
is the large pool of accomplished and well-funded research laboratories at the UW and FredHutch who, year
after year, host the fellows; and the support of pre-doctoral and training programs that participate in and with
which the program dovetails. From this very large pool of investigators the program draws the core group of
faculty mentors listed in this application; all accomplished scientists who have mentored and/or advised in the
past and demonstrated a commitment to mentoring undergraduate, graduate, and post-doctoral UR fellows.
UW PREP will facilitate matching each fellow with a research mentor to conduct a year long,
hypothesis-driven research project. Co-mentoring by the program leadership will provide advice about
graduate school application. Professional development activities based on each fellow’s individual
development program (IDP) will improve scientific skills in writing, presentations, the interpretation of the
scientific literature and bioethics; supplemental didactic training will be provided, as needed, to fill gaps in
preparation, based on the IDP. Self-confidence and scientific identity will be fostered through a variety of
scientific and social forums with URM groups in Seattle.
UW PREP goals are as follows: (i) all (100%) fellows will apply for admission into biomedical
graduate or MD/PhD programs; (ii) at least 85% of them will successfully enter first-rated pre-doctoral graduate
programs; (iii) at least 80% of them will graduate with a doctoral degree.

Public health relevance
The UW PREP program has increased the diversity of the biomedical research community by annually recruiting six recent graduates belonging to underrepresented communities, and by preparing them for successful application to, and graduation from, first-rated biomedical pre-doctoral programs. The fellows will engage in a year-long intensive research project in premier research laboratories, and receive professional training in scientific writing, public presentations, and scientific communication; through UW graduate courses and instruction in the bioethical conduct and rigorous practices in research. All fellows will apply for admission to multiple PhD or, for 1-2 fellows each year, MD/PhD programs; at least 85% of them will be accepted into pre-doctoral graduate programs and at least 80% of these will graduate with a doctoral degree, as accomplished in the first three funding periods.